ANIMAL HEALTH RESOURCES IMPROVEMENTS

The long-term objective of the Animal Health Resources Program is to facilitate biomedical research at the Fred Hutchinson Cancer Research Center by providing quality animal care, by offering a broad range of technical (e.g., surgical) support services, and by eliminating complications of animal research due to intercurrent disease. The specific aims of this proposal are threefold. First, we plan to upgrade the general level of animal care throughout our facility and to ensure future accreditation by replacing worn and unreliable equipment (an autoclave and ten dog runs). Second, we propose the renovation of existing space for a much needed surgical facility for dog and rabbit studies, currently conducted off-site or not at all. Third, we will expand our current, disease-free microisolator rodent housing system through the purchase of 100 additional cages for rats. Support as requested will enable the Animal Health Resources to upgrade general operations, maintain accreditation standards, and meet its service goals for the coming years.